HEPATOTOXICANT INDUCED IMMUNE SUPPRESSION THROUGH TGF-BETA RELEASE

The overall goals of this Project are to determine how selected Superfund chemicals influence immunity and inflammation and to understand the mechanisms and potential health consequences of such effects. The aims for the next granting period were driven by a need for knowledge of interactions among chemicals and the specific and nonspecific components of the immune system. Specific hypotheses to be tested derive from the recent findings of the investigators of the three subprojects. This Subproject is a new addition based on the observation that administration to animals of certain hepatotoxicants at doses that cause modest liver pathology results in release of a serum factor that is immunosuppressive. Recently, this factor has been identified as transforming growth factor-beta(TGF-beta). During the next granting period, a battery of functional assays will be used to determine whether alterations in immunocompetence are mediated by TGF-beta alone or involve other factors, such as overproduction of interleukin-2 by helper T-cells. The studies proposed in this Project will employ cellular, isolated organ and whole animal models and entail molecular, biochemical and morphologic methods that include techniques such as cell imaging and flow cytometry. Accomplishing goals of this Project as well as aiding in the toxicologic evaluation of products of remediation will involve considerable interaction not only among Project investigators but also with investigator of other projects and cores. Results from these studies will increase understanding of the mechanisms and potential health consequences of interactions of Superfund chemicals with the immune system.